Fingerprinting Spatiotemporal Patterns of Brain Maturation with Combined Diffusion-Relaxometry Microstructure Imaging

PROJECT SUMMARY AND ABSTRACT
Brain maturation involves intricate and concurrent cellular changes throughout childhood and adolescence. With
the capability to noninvasively track whole brain development, MRI holds the promise to enhance our
understanding of normative brain maturation and facilitate the identification of neurodevelopmental disorders.
However, the commonly used measures from structural and diffusion MRI, such as cortical thickness or fractional
anisotropy, lack the sensitivity and specificity required to differentiate between biological processes such as
synaptic pruning and myelination. These processes influence the diffusion MRI signal, not just through
morphological changes in cellular organization but also via physical properties like T2/T2*, affected by alterations
in chemical composition such as iron concentration. Current neuroimaging measures are confounded by these
multifaceted influences, at the expense of validity and interpretability in brain maturation studies. A central
hypothesis of this proposal is that these confounding influences can be disentangled through the next generation
combined diffusion-relaxometry microstructure imaging and myelin specific imaging, providing increased
statistical power in detecting developmental changes spatiotemporally. To test the hypothesis, we will develop
acquisition and analysis methods for combined diffusion-relaxometry microstructure imaging and myelin water
imaging that can be applied to neurodevelopmental populations. The goal is to collectively provide a unique
fingerprint of neurodevelopment by disentangling the developmental changes in cell body density, neurite density,
cell size, subcellular T2/T2*, and myelination. The K99 phase will supplement the applicant’s expertise in
microstructural imaging methods, by providing training in developmental neuroscience, with a focus on
understanding biological factors relevant to microstructural development; statistical approaches to analyzing age
effects on brain-area dependent microstructure; and study design and administration for adolescent
neuroimaging studies. This training will position the applicant well for collecting pilot datasets and validating the
proposed methods during the R00 phase. Leveraging the latest advances in human MRI scanners, this project
will undertake significant innovations in imaging acquisition, microstructural modeling, and quantitative analysis.
The objectives include: i) Develop practical, highly accelerated acquisition protocols for detailed microstructure
mapping with cutting-edge MRI sequences and commercially available ultra-strong diffusion gradients; ii)
Develop machine learning tools for unbiased and efficient estimation of microstructural parameters at the
individual level; iii) Develop a cross-subject, registration-free microstructural analysis pipeline that is robust to
morphological differences across age groups; iv) Collect pilot datasets from a developmental cohort and assess
the power of the developed microstructural fingerprint to detect cellular changes. We will share the rich datasets
and novel insights of brain maturation through this project. We will disseminate the optimized imaging protocols
and computational tools to the scientific community, with the aim of benefitting a wider range of applications.

Public health relevance
PROJECT NARRATIVE Charting the continuous cellular changes of the brain is critical for studying neurodevelopment, yet it remains challenging due to the limited sensitivity and specificity of in vivo imaging methods. This project will capitalize on the latest advancements in imaging systems and computational techniques to develop practical tools that can disentangle cellular microstructural and macromolecular development across the brain. This will enable a deeper understanding of typical brain maturation and, ultimately, the origins and mechanisms of atypical development.